Genetic and Molecular Mechanisms of Heart Disease

PROJECT SUMMARY / ABSTRACT
Heart disease is a leading cause of morbidity and mortality, and the incidence of heart failure (HF) is growing, while
costing our public healthcare system over $30B per year. HF coincides with significant perturbations in cardiac gene
regulation, mitochondrial function, and ion channel expression and activity, and my research program embodies three
independent projects related to these pathological processes. For Project #1, our goal is to define microRNA (miR)
targeting events and their biological-relevance in heart and to understand the clinical significance of SNPs that alter
cardiovascular miR functions. MiRs play key roles in cardiac biology and disease; however, identifying their targets
is critical to understanding how. There remains a lack of empirical miR targeting data from primary tissues, and this
has slowed the translational impacts of miR research. We address this by employing high-throughput methods to
generate global miR-target interactomes in heart tissues. Our hypothesis is that heart disease is influenced by rewired
miR-target interactions and SNPs perturbing these interactions. We are filling knowledge gaps regarding the
mechanistic targets of cardiac miRs by defining and comparing miR binding sites in nonfailing and diseased human
hearts. Our data point to clinically-relevant SNPs that may modulate cardiomyopathy- and arrhythmia-related miR-
target interactions, and we functionally test these interactions and determine if SNPs are linked to clinical outcomes
in patients. For Project #2, our goals are to better define the function of mitoregulin and establish its role in cardiac
ischemia-reperfusion (IR) injury. Upon IR, mitochondrial Ca2+ overload and ROS trigger mitochondrial permeability
transition (mPT) pore opening to induce cell death. We previously discovered that a heart/muscle-enriched long “non-
coding” RNA encodes a mitochondrial microprotein that increases mitochondrial respiration and Ca2+ retention
capacity, while reducing ROS; we named this protein mitoregulin (Mtln). The precise molecular function of Mtln
remains unclear, and Mtln’s influence on cardiac stress has not been adequately studied. We are working to address
our central hypothesis that 1) Mtln protects against cardiac IR injury by delaying Ca2+- and ROS-triggered mPT and/or
by maintaining mitochondrial membrane integrity, and 2) Mtln overexpression (OE) will blunt cardiac IR injury and
HF, providing a new therapeutic avenue. For Project #3, our goals are to define regulatory paths controlling SCN5A
(encodes the primary cardiac Na+ channel, NaV1.5) and to characterize non-canonical actions of NaV1.5 beyond its
known role in conduction. We discovered a SNP that bolsters miR-mediated silencing of SCN5A and associates with
lower cardiac NaV1.5 levels, conduction slowing, and increased non-arrhythmic death in HF patients. Our central
hypothesis is that lower SCN5A/NaV1.5 expression elevates one’s susceptibility to subclinical cardiac pathologies
that transform into significant risk in the setting of HF. We are defining two novel modes of SCN5A/NaV1.5 regulation
and examining underappreciated roles for NaV1.5 in cardiomyocyte metabolism and oxidative stress to better
understand how lower NaV1.5 could worsen HF. Overall, these projects will advance our mechanistic understanding
of heart disease at both the molecular and genetic level, with significant potential to someday improve clinical care.

Public health relevance
PROJECT NARRATIVE Public Health Relevance: Heart failure and associated sudden cardiac death are leading causes of morbidity and mortality for both men and women worldwide. The prevalence and adverse societal impacts of heart failure are growing, costing our public healthcare system more than $30 billion annually. Heart failure coincides with significant perturbations in cardiac gene expression, mitochondrial function, and ion channel expression and activity, and our overall goals are 1) to improve our understanding of the biological and therapeutic relevance of microRNAs by better defining their gene regulatory actions in normal and diseased hearts, 2) to characterize new pathways controlling mitochondrial responses to myocardial ischemia-reperfusion injury, and 3) to define novel regulation and non-canonical roles of cardiac sodium channels.